Automating Delirium Identification and Risk Prediction in Electronic Health Records (Supplement)

$%675$&7 'HOLULXP RU DFXWH FRQIXVLRQDO VWDWH DIIHFWV RI KRVSLWDOL]HG ROGHU DGXOWV ZLWK WKH DGGHG FRVW RI FDUH HVWL PDWHG WR EH XS WR ELOOLRQ $OWKRXJK RULJLQDOO\ FRQFHSWXDOL]HG DV D WUDQVLHQW GLVRUGHU GHOLULXP LV QRZ UHFRJQL]HG WR KDYH VLJQLILFDQW FRQVHTXHQFHV LQFOXGLQJ LQFUHDVHG ULVN RI GHDWK IXQFWLRQDO GHFOLQH DQG ORQJWHUP FRJQLWLYH LPSDLUPHQW $V XS WR RI FDVHV DUH QRW UHFRJQL]HG E\ SURYLGHUV WKHUH LV DQ FULWLFDO QHHG IRU DGYDQFHG PHWKRGV WR LGHQWLI\ GHOLULXP IRU FOLQLFDO DQG UHVHDUFK SXUSRVHV DQG WR VWUDWLI\ SDWLHQWV EDVHG RQ GHOLULXP ULVN 8QIRUWXQDWHO\ VXUYHLOODQFH RI GHOLULXP LV WLPH FRQVXPLQJ UHVXOWLQJ LQ IHZ LQVWLWXWLRQV LPSOHPHQWLQJ V\V WHPDWLF VFUHHQLQJ SURFHGXUHV RQ DOO ROGHU DGXOWV 5HVHDUFK VWXGLHV WKDW XVH UHJXODU GHOLULXP VFUHHQLQJ DVVHVVPHQWV DUH W\SLFDOO\ VPDOO VLQJOH LQVWLWXWLRQ VWXGLHV LQ D VXEVHW RI SDWLHQWV WKDW GR QRW UHOHDVH WKHLU GDWD IRU UHSOLFDWLRQ GXH WR FRQFHUQ RYHU SULYDF\ ODFN RI WHFKQLFDO H[SHUWLVH RU RWKHU FRQFHUQV (SLGHPLRORJLFDO VWXGLHV WKDW GR QRW XVH GHOLULXP VFUHHQLQJ DVVHVVPHQWV UHO\ RQ SUR[\ PHDVXUHV VXFK DGPLQLVWUDWLYH FRGHV ZLWK VHQVLWLYLW\ DV ORZ DV LQVWHDG RI FKDUW UHYLHZ ZKLFK FDQ UHFRYHU XS WR RI GHOLULXP FDVHV $GYDQFHG PHWKRGV VXFK DV QDWXUDO ODQJXDJH SURFHVVLQJ 1/3 DQG PDFKLQH OHDUQLQJ 0/ KDYH WKH SRWHQWLDO WR DXWRPDWH WKLV FKDUW UHYLHZ SURFHVV DQG IDFLOLWDWH ODUJHVFDOH VWXGLHV RI GHOLULXP EXW DUH KDPSHUHG E\ ODFN RI VXLWDEOH GDWD IRU DOJRULWKP GHYHORSPHQW :H SURSRVH WR OHYHUDJH V\VWHPDWLF GHOLULXP VFUHHQLQJ DYDLODEOH WKURXJK WKH 8QLYHUVLW\ RI $ODEDPD RI %LUPLQJKDP 8$% 9LUWXDO $FXWH &DUH IRU (OGHUV $&( TXDOLW\ LPSURYHPHQW SURJUDP WR FUHDWH DQG UHOHDVH D GHLGHQWLILHG GHOLULXP GDWDVHW WR DGGUHVV WKH GDWD DQG GLDJQRVLV JDS LQ HSLGHPLRORJLFDO VWXGLHV RI GHOLULXP 2XU 9LUWXDO $&( SURJUDP KDV GHWHUPLQHG GHOLULXP VWDWXV RQ PRUH WKDQ SDWLHQWV DFURVV D VL[\HDU SHULRG SURYLGLQJ D ULFK VHW RI GDWD IURP ZKLFK WKLV SURMHFW ZLOO GUDZ :H ZLOO WHVW WKH K\SRWKHVLV WKDW RXU WUDQVIHU OHDUQLQJ EDVHG GH LGHQWLILFDWLRQ PHWKRG FDQ DVVLVW DQQRWDWRUV WR PRUH UDSLGO\ GHLGHQWLI\ FOLQLFDO WH[W RSHQLQJ WKH GRRU WR ODUJHU IDVWHU PRUH ZLGHO\ DYDLODEOH GDWDVHW UHOHDVHV 7R YDOLGDWH WKH XWLOLW\ RI WKH IXOO GDWDVHW ZH ZLOO GHWHUPLQH WKH VWDWLVWLFDO SRZHU RI RXU GHLGHQWLILHG FRUSXV WR GHWHFW GLIIHUHQFHV EHWZHHQ SDUWLFLSDQWV ZLWK DQG ZLWKRXW GHOLULXP LQ FRPPRQO\ XVHG 0/ VWXG\ GHVLJQV 2XU GHOLULXP GDWDVHW UHOHDVH FRQWDLQLQJ GHLGHQWLILHG FOLQLFDO QRWHV DQG DVVRFLDWHG VWUXFWXUDO GDWD ZLOO EH RQH RI WKH ODUJHVW WH[W FRUSRUD HYHU UHOHDVHG DQG WKH RQO\ WH[W LQFOXVLYH FRUSRUD VSHFLILFDOO\ IRU WKH VWXG\ RI GHOLULXP 7KH SURSRVHG GDWDVHW ZLOO EH DYDLODEOH IRU GRZQORDG RQ 3K\VLRQHW ZLWK D 'DWD 8VH $JUHHPHQW '8$ WR IDFLOLWDWH IXUWKHU GHYHORSPHQW RI 1/3 DQG 0/ DSSURDFKHV IRU GHWHUPLQLQJ GHOLULXP VWDWXV ULVN IDFWRUV DQG VHTXHODH DW RWKHU LQVWLWXWLRQV DQG LQ RWKHU SRSXODWLRQV E\ WUDQVIHU OHDUQLQJ 5HOHDVH RI RXU GHLGHQWLILFDWLRQ DOJRULWKPV DQG PHWKRGRORJ\ ZLOO DOVR IDFLOLWDWH WKH GHYHORSPHQW DQG UHOHDVH RI ODUJHVFDOH WH[W FRUSRUD LQ RWKHU GLVRUGHUV

Public health relevance
PROJECT NARRATIVE Delirium, or acute encephalopathy, is a common, serious condition in older adults, but large-scale studies of delirium are hard because delirium is under-diagnosed in medical records. Humans are needed to read notes and find most cases of delirium, making delirium research slow, expensive or not done at all. Our proposal will use new advances in natural language processing and machine learning to fix this problem, by creating and sharing a labelled delirium dataset containing clinical notes that protects personal information.